Administrative Core

CORE SUMMARY/ABSTRACT- ADMINISTRATIVE CORE
The Administrative Core (AC) will lead and provide oversight of the Yale Superfund Research and Training
Program (YSRTP) and ensure it achieves its goal to protect public health by characterizing emerging water
contaminants, elucidating their toxicity, assessing exposures to human populations, and detecting and
remediating contamination. The AC is comprised of a highly qualified administrative team that will lead the
YSRTP which includes: 1) three additional cores (Data Management & Analysis, Community Engagement, and
Research Experience and Training Coordination) and 2) four research projects (two biomedical research projects
(BMR) and two environmental science and engineering projects (ESE)). The AC will coordinate research projects
and cores to: 1) create new knowledge related to potential health effects, exposure detection, and remediation
of the emerging drinking water contaminant 1,4-dioxane (1,4-DX) and common mixtures of co-occurring
contaminants found at Superfund sites and in water supplies that are of high interest to the Superfund Research
Program (SRP) and its stakeholders, 2) promote research translation, and dissemination and utilization of the
findings from the scientific activities in the YSRTP, and 3) integrate efforts with other Superfund Research and
Training Programs, the NIEHS, the EPA and other stakeholders to achieve a greater national (and international)
impact for policy change.
The well-qualified personnel engaged in the AC have been carefully selected to ensure that our YSRTP will meet
its objectives addressing the four SRP mandates. The Research Translation Coordinator (RTC) and the Deputy
Directors will serve as catalysts and as powerful conduits for communication and coordination with the projects
and cores. The AC staff members have a long history of managing multi-disciplinary, multi-investigator
extramural programs and institutional Centers. In addition, the AC has obtained strong institutional support from
all Yale Schools participating in the YSRTP. Through the support provided by the Schools at Yale University, the
YSRTP will be recognized as an Institutional Center that will enhance the visibility of the SRP and ensure
centralized monetary support. Our External and Internal Advisory Committees will help guide and evaluate our
program. The leadership and personnel of the AC are highly qualified and eager to manage the YSRTP
effectively to support our Core and Project PIs and trainees as we pursue the NIEHS-SRP mission.

Public health relevance
PROJECT NARRATIVE- ADMINISTRATIVE CORE The overarching aim of the Administrative Core (AC) is to ensure the success of the Yale Superfund Research and Training Program (YSRTP) in advancing public health through effective leadership and oversight. The AC will coordinate the translation of the YSRTP research that entails new knowledge about adverse health effects, exposure detection, fate and remediation of emerging water contaminants, and integrate its efforts with other Superfund Research and Training Programs and the NIEHS to have a greater national (and international) impact.